Lung Macrophage Memory Development and Responses in Secondary Pneumonia and Sepsis

Project Summary
Increased susceptibility to secondary bacterial pneumonia is a significant clinical complication of pulmonary viral
infections. The characterization of molecular players that leave immunological scars/memory for sustained
periods after clinical recovery from viral infections is vital for preventing secondary pneumonic infections. Our
current knowledge in this regard is vastly limited, and the studies so far have mainly focused on “immunologically
tolerized” dendritic cells and macrophages developing as a result of immunosuppressive microenvironment
established upon resolution of primary infection. In this application, based on our strong supportive data
(communicated to Nature Immunology) showing that IFNγ produced during pulmonary influenza infection
imprints an immunological memory in alveolar macrophages (AMs) that drive a pathologic innate memory
response to a subsequent bacterial pathogen, we propose to identify the novel mechanism of transcriptional
reprogramming in these immunologically trained AMs. In this regard, pausing of RNA polymerase II (Pol II) at
the transcriptional start site of most mammalian genes and its release onto the gene body for rapid transcription
upon cellular activation is a key step in determination of transcriptional activation. By using state-of-the art
genome-wide techniques, we have found that IFNγ responsive genes in macrophages acquire Pol II enrichment
at the promotor-proximal regions during their transcriptional induction phase that controls simultaneous
elongation and subsequent gene expression. We termed this novel mechanism Acquired Promoter-proximal Pol
II enrichment (APPe), and propose that APPe is responsible for IFN-induced memory phenotype in influenza
infection. Further, we found that chromatin modifier Protein Arginine Methyltransferase 8 (PRMT8) is involved in
IFN-induced memory response by establishing APPe early in trained-macrophages. Based on these data, we
will determine: (Aim 1) how PRMT8 controls IFN-induced memory transcriptional reprogramming responsible for
an earlier and greater transcription of IFN-responsive genes in these trained AMs upon reactivation during
secondary bacterial infection, and whether PRMT8 deficiency ameliorates pathology and reinstates an
appropriate immune response to secondary bacterial infection by both Gram-negative (Klebsiella pneumoniae)
and Gram-positive bacteria (Staphylococcus aureus, and Streptococcus pneumoniae/ pneumococcus); (Aim 2)
how transcriptional memory outcomes in AMs during secondary bacterial pneumonia are regulated through the
rate-liming step of APPe via PRMT8 mediated APPe occurrence for an early, uncontrolled transcription of target
genes that are involved in cytokine storm and later severe sepsis. The successful completion of proposed work
will address a major gap in our knowledge of mechanisms dictating macrophage functions during influenza and
subsequent bacterial infections, which will have implications for future therapeutic measures.

Public health relevance
Project Narrative Increased susceptibility to secondary bacterial pneumonia after recovery from primary influenza infection is an important clinical complication. Host immune factors, rather than pathogen associated molecules, are now well recognized as central players in determining susceptibility to secondary infection. However, the underlying mechanisms are poorly understood. Our proposed studies elucidate a novel transcriptional gatekeeping mechanism involved in dysregulated immune response of alveolar macrophages to secondary bacterial infection. We identify immune and epigenetic factors that imprint an immunological memory in alveolar macrophages during prior influenza infection, that causes these cells to mount an early and exaggerated inflammatory response upon subsequent secondary bacterial infection, resulting in sepsis and severe disease. Our proposal identifies novel therapeutic targets that will have significant impact on designing measures to correct the innate immune cell dysfunction, not only in secondary infections but also in other airway diseases.